Cell-Based HTS Campaign to Identify Negative Allosteric Modulators of the Leukemia-associated Tyrosine Kinase, BTK”.

Abstract. The non-receptor tyrosine kinase Bruton’s tyrosine kinase (BTK) is essential for the development and
function of B cells. Small molecule inhibitors of BTK (BTKi’s) like Ibrutinib (IMBRUVICA®) have revolutionized
the treatment of B cell malignancies including chronic lymphocytic leukemia (CLL), the most common form of
leukemia in adults. Ibrutinib, and related next-generation FDA-approved BTKi’s, covalently and irreversibly bind
to cysteine 481 (C481) in the ATP binding pocket of the kinase domain. Unfortunately, intrinsic and acquired
resistance to ibrutinib develops in the majority of CLL patients, often due to mutations in the BTK active site
cysteine essential for drug action. While the C481S point mutation is most common, double mutations involving
the BTK gatekeeper residue (T474) in addition to C481 produce super resistance to ibrutinib, acalabrutinib, and
zanubrutinib. Durable responses to orthosteric ATP-site BTKi’s in the cancer setting are therefore limited by
these drug resistance mechanisms, resulting in the evolution of inhibitor-resistant tumor cell clones. In addition,
toxicity and adverse events cause discontinuation of BTKi therapy in up to 26% of patients. In this proposal,
which is responsive to PAR-23-264: Assay development and screening for discovery of chemical probes,
drugs or immunomodulators, we will capitalize on our advanced knowledge of BTK structure and how the
non-catalytic regulatory domains of BTK control kinase function. We have developed and optimized a suite of
cell-based high-throughput and high content screening (HTS & HCS) assays to identify allosteric (non-ATP site)
inhibitors of BTK dimerization, a prerequisite for BTK autophosphorylation and catalytic activation. Our team of
investigators combines expertise in Tec family tyrosine kinases including BTK biochemistry and structural biology
(Andreotti), broad experience (in both the pharmaceutical industry and academia) in HTS/HCS drug discovery
(Johnston), expertise in pharmacology and molecular oncology (Smithgall) and medicinal chemistry (Iyer). In
Aim 1 we will conduct an HTS campaign using a statistically validated BTK dimerization NanoBiT assay (based
on NanoLuc complementation) to identify compounds that block BTK dimerization and subsequent activation in
cells. Aim 2 will confirm primary HTS actives in counter screens and orthogonal assays, and prioritize hits based
on potency and chemical tractability. We will determine whether BTK dimerization inhibitors are cytotoxic to B-
cell cancers and explore synergy with approved BTKi’s and other cancer drugs to enhance killing. Aim 3 makes
use of our established biochemical, cellular, and structural approaches to fully characterize hit compounds that
block BTK dimerization, kinase activity, and signal transduction. Successful completion of the proposed HTS
campaign will identify novel small molecule allosteric inhibitors that disrupt BTK signaling. Drugs developed from
these compounds are anticipated to suppress emergence of acquired resistance mutations that abolish the
efficacy of ibrutinib and related drugs that target the BTK active site.

Public health relevance
Narrative Treatment of chronic lymphocyte leukemia and other B cell malignancies has advanced dramatically with the use of Ibrutinib (IMBRUVICA®) and related next generation kinase inhibitors. However, the efficacy and durability of these drugs is severely limited by intrinsic resistance and acquired resistance mutations that render these drugs ineffective. In addition, drug toxicity and adverse events cause discontinuation of therapy in a substantial proportion of patients. This proposal devises a new way to approach kinase inhibition and successful completion of the goals will yield novel small molecules as lead compounds. The innovative approach provides an avenue to overcome resistance to currently used therapies.